Recognition of Cellular Targets by single and double-stranded nucleic acids

Abstract
Background: My laboratory works at the interface of cell biology and nucleic acid chemistry to
modulate translation, splicing, and transcription. Ideal projects have three features: 1) Novel
oligonucleotides that allow us to probe the strengths and weakness of the chemical modifications; 2)
Challenging nucleic acid structures or mechanisms for nucleic acid-mediated regulation; and 3) The
opportunity to gain insights into significant biological process or therapeutic development. For 2021-
2026 our central goal is to investigate mechanisms of RNA recognition to gain greater insights into
cell physiology and therapeutic development.
Since 2016, several nucleic acid drugs have been approved and oligonucleotide medicine is
poised to have a significant impact on broad patient populations. One obstacle to realizing this
potential is an incomplete understanding of RNA recognition in cells. For example, while over 1000
peer-reviewed publications appear every month that cite the term “miRNA”, we lack the detailed
insights necessary to necessary to predict function or appreciate the roles of RNA in complex
biological processes. Validation of proposed effects is often problematic and the predictive power for
studying novel genes is limited. We will focus on two project areas involving the recognition of RNA
within either the nuclei or cytoplasm of human cells.
Cooperation of miRNAs and protein factors during RNAi. We will gain fundamental
insights into the mechanism of RNA using knock out cell lines deficient for key RNAi factors including
proteins of the argonaute (AGO) and trinucleotide repeat containing protein 6 (TNRC6) families. We
will combine mass spectrometry, RNAseq, and cross linking immunoprecipitation (CLIP) to define
where interactions occur how the number of protein or miRNAs affect the impact on gene regulation.
We will first examine detailed mechanisms for regulation in cell cytoplasm. We will then apply these
lessons to investigate the consequences of miRNA recognition in both cell cytoplasm and nuclei.
Novel mechanisms and disease targets. We will gain a better understanding of two
diseases caused by mutant RNAs, Fuch's Corneal Endothelial Dystrophy (FECD) and Friedreich's
Ataxia (FA). One goal is to develop more potent compounds to facilitate drug development. A second
goal is to better understand mechanisms of action. Both diseases involve nuclear noncoding RNAs,
and we will use synthetic nucleic acids as tools to probe disease mechanism and better appreciate
how a small number of mutant RNA molecules can cause late-onset degenerative diseases.

Public health relevance
Project Narrative Our goal is to understand the recognition of nucleic acids inside cells. One focus will be RNA- mediated recognition in cell nuclei. We will use our understanding of mechanism to develop new methods to control expression of genes involved in disease, including the genes responsible for Friedreich's Ataxia and Fuchs' Dystrophy.